Electronic Health Record Phenotyping for Case Detection and Prediction of Emergency Department Visits for Child and Adolescent Suicide Attempts

PROJECT SUMMARY/ABSTRACT
The candidate requests support for a five-year program of training and research to better understand how
electronic health record phenotyping and other computational methods can bolster detection and prediction of
suicide attempts by youth ages 10 to 17 using existing medical record data. In the proposed training plan, the
candidate will build upon her previous experiences in social psychology, clinical informatics, and clinical child
and adolescent psychiatry to perform a multidisciplinary project at the University of California, Los Angeles
Health System. Her training plan includes developing skills and knowledge in 1) analysis of natural language
data, 2) development of risk algorithms in healthcare settings to improve suicide prevention, 3) basic qualitative
research skills including modified Delphi Panel approach, and 4) the responsible conduct of research. Suicide
is the second leading cause of death of young people over 10 years old in the United States and suicide
attempts among children are common, costly and preventable. There is a need to better detect children who
have received medical care for suicidal behavior, discover children at high risk for future attempts who warrant
specialized clinical attention, and connect suicide attempt detection and risk prediction algorithms with
clinically-useable tools that can inform medical decision-making for children and families. This study proposes
that electronic health record phenotyping, a method of standardizing case detection using clinical note text and
structured medical record data, may offer improved detection and personalized risk prediction for children and
complement existing suicide prevention efforts. In the proposed research, using a cross-sectional design,
Aim 1 will focus on adaptation of a method (electronic health record phenotyping) to detect emergency
department visits for suicide attempts by children using electronic health records. Then, using a case-control
design, Aim 2 will focus on development of risk prediction models of emergency department visits for suicide
attempts by children using longitudinal electronic health records over two years. Aim 3 will focus on
assessment of the validity, acceptability, usability, feasibility, and overall utility of applying electronic health
record phenotyping to detection and risk prediction of attempts using a modified Delphi panel approach. This
plan will parallel a training plan building skills and knowledge to bridge informatics, computational methods,
and clinical child psychiatry. The broader aim for this research is to better understand the developmentally-
varied, transdiagnostic path toward suicidal behavior in children. By applying computational advancements to
mine existing healthcare data, this research is an initial step to enhance pediatric-specific signal detection and
support personalized prediction of suicidal behavior, in turn, setting the stage for deployment of these
approaches in clinical settings where providers, youth, and families may directly benefit.

Public health relevance
PROJECT NARRATIVE Suicide is the second leading cause of death among children 10 to 14 years old. Our ability to predict and intervene before a child attempts suicide is limited by substantial developmental variation in the clinical presentations and precursors of suicidal behavior across the age spectrum. This study seeks to improve detection and prediction of suicide attempts among children by using electronic health record phenotyping and computational methods with the long-term goal of designing more effective and targeted suicide prevention interventions tailored to the needs of the individual child.